Intersections of matrix biology with inflammation in a new model of gout

Hyperuricemia is fundamental in promoting the formation and accumulation of tissue deposits of
monosodium urate crystals in gout, a high prevalence disease in Veterans. Urate crystals deposited in the joint
promote acute, episodic flares of painful and incapacitating inflammatory arthritis by multiple pathways. Most
importantly, urate crystals induce monocyte and macrophage NLRP3 inflammasome-mediated IL-1b release,
and phagocyte influx and activation. Chronic inflammation lies beneath acute gout flares, including formation of
articular tophi, which cause persistent synovitis and pannus-like erosive joint disease. However, several key
aspects of gout pathogenesis remain unclear. In this light, asymptomatic hyperuricemia is over 5 times as
prevalent than gout, and synovial fluid urate is enriched relative to serum urate in gout. Thus, passive filtering
into the joint of excess circulating urate
cannot be the only factor promoting tissue urate crystal deposition and
symptomatic arthritis in gout. Furthermore, beyond high body urate burden, native factors that limit only ~15%
of gout patients to develop palpable tophi in “tophaceous gout” are unclear. Better understanding factors that
limit tophaceous gout, and their biomarkers, is vital due to association with erosive joint damage.
To study novel gout prevention and therapy targets, we propose to test a paradigm-shifting core
hypothesis for a gout regulation via intersection of inflammation with altered homeostasis of the extracellular
matrix O-glycoprotein boundary lubricant lubricin. We specifically posit that the major gouty arthritis NLRP3/IL-
1b driver intersects with the homeostasis of lubricin to increase articular urate crystal deposition, inflammation,
and disease progression in gout. Lubricin is an established, constitutive suppressor of experimental gouty
inflammation. We observe that IL-1b induces xanthine oxidase and uric acid generation by macrophages, an
effect blocked by exogenous lubricin. We find that lubricin markedly suppresses urate crystal formation in vitro.
We also have characterized a remarkable “experiment of nature” in a 22 year old female female without
hyperuricemia, who developed rapidly progressive crystal-proven gout, with classic and frequent acute flares,
and erosive, destructive arthritis, affecting the feet, wrist, and hip. The proband had a heritable NLRP3 gain of
function variant, an inflammatory profile of serum biomarkers and the whole blood transcriptome, attenuated
serum levels of lubricin, and collective evidence consistent with altered lubricin homeostasis. Our model is that
paucity of lubricin in “common gout”, due to heterogeneous mechanisms, enhances articular uric acid and
increases the capacity of monosodium urate crystals to form in the joint. We thereby posit that articular lubricin
deficiency, suppressible by injectable lubricin supplementation, promotes more severe acute and chronic gouty
phenotypes in vivo. Translationally impactful studies will test our model by moving from in vitro to mouse to
human studies. In doing so, we will test and compare mucin, and N- and C-terminal domain requirements for
lubricin to limit urate crystal formation and macrophage xanthine oxidase activity, and to suppress selected
gout pro-inflammatory mechanisms in macrophages. We will test the specific hypothesis that lubricin deficiency
promotes ineffective resolution of IL-1b and urate crystal-induced acute articular inflammatory responses. Last,
in a large, cross-sectional analysis of sera, we will test for relationships of more frequent gouty arthritis flares
and tophaceous gout with low serum levels of lubricin, and certain entirely novel serum biomarkers of lubricin
homeostasis pertinent to gout, including lubricin-degrading Cathepsin G activity, the Cathepsin G co-activator
Lactoferrin, two inhibitors (Thrombospondin1 (TSP1/THBS1) and SERPINB6) of lubricin-degrading proteases,
and the Cathepsin G substrate APP (Amyloid Precursor Protein). Completion of this work is projected to
elucidate novel serum biomarkers to help guide gout treatment strategy and intensity, and new therapy targets
to limit urate crystal deposition, acute and chronic synovitis, and joint damage in the disease.

Public health relevance
Gout is a very common disease in Veterans and other USA adults, caused by elevated circulating levels of uric acid, and consequently by deposits of crystals containing uric acid that cause flares of characteristically very painful and incapacitating arthritis, and can lead to joint damage. There is unmet need for more precise ways of preventing and treating the disease. We have identified novel mechanisms that promote uric acid buildup in the joints, and which also can increase arthritis and accelerate joint damage. We will test and define the importance of these mechanisms in bench laboratory studies, experiments in mice with genetic deficiency of a critical lubricant and anti-inflammatory mediator in joint tissue, and in analyses of samples from patients with gout and differing disease severity. The work will advance potential new gout prevention and therapy targets to limit acute and chronic inflammation and joint damage.